A Computer Aided Diagnosis(CAD) Algorithm for Identification of Dysplasia in Patients with Barrett Esophagus

ABSTRACT The goal of this project is to develop a based computer aided diagnosis (CAD) algorithm for identification of regions at risk for developing esophageal adenocarcinoma (EAC) in optical coherence tomography (OCT) scans of the esophagus. EAC is one of the deadliest cancers with a 5-year survival rate of less than 20%; yet the standard of care for detecting precursors to EAC is widely recognized to be inadequate. Just recently, a study found that 25% of patients who underwent a standard endoscopic surveillance exam which was found to be “clear” then went on and progressed to EAC within one year. Clearly today’s approach is not working and a significant percentage of disease is being missed. While comprehensive esophageal OCT imaging has shown great potential in addressing this unmet clinical need, one of the main limiters to wider adoption and impact of this technology is the challenge of interpreting the large volume of high-resolution images in real-time. A CAD algorithm would allow OCT to realize its promise in this field and significantly improve the standard of care. Here we propose the development of a deep learning CAD algorithm which will operate on a full patient level volumetric dataset with awareness of the anatomy, robust against image quality and motion artifacts, and trained and validated against a large dataset (>1000 patients). We will aim to reach a sensitivity and specificity of 90/80% based on a threshold set by the American Society for Gastroenterology (ASGE) for the performance of advanced imaging in the detection of high grade dysplasia in BE.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop a computer aided diagnosis (CAD) algorithm for use with the NinePoint Medical OCT imaging system and provide early detection of pre-cancerous lesions. Earlier detection leads to earlier treatment, more positive health outcomes for patients and lower healthcare system costs.